DNA adductome of human bladder from the tobacco exposome

Summary
More than 70 chemicals in tobacco smoke are carcinogens. Tobacco smoking is a risk factor for bladder cancer;
however, despite many years of study, the principal chemicals in tobacco smoke and environment that damage
DNA of the bladder are unknown. Aromatic amines (AAs) and heterocyclic aromatic amines (HAAs) arise in
tobacco smoke and are responsible for much of the mutagenicity in urine of smokers. Some AAs (and possibly
HAAs) are bladder carcinogens, and also induce liver, bladder, and colorectal cancer in rodents, and likely
contribute to these cancers in humans. 4-Aminobiphenyl (4-ABP) is a human bladder carcinogen; however,
several alkylanilines and structurally related HAAs occur in tobacco smoke at levels up to 100-fold greater than
4-ABP. Some epidemiological studies have linked N-nitroso compounds and polycyclic aromatic hydrocarbons
as risk factors for bladder cancer. Robust measurements of DNA adducts are important to understand the
chemicals in tobacco smoke, the environment, and diet that damage the bladder and may contribute to bladder cancer.
Apart from 4-ABP, the chemicals in tobacco smoke that damage bladder DNA are unknown. The objective of
this application is to apply robust screening tools to identify DNA adducts derived from exogenous and
endogenous sources that damage bladder DNA. We will employ our newly developed mass spectrometry (MS)
adductomic tools to identify the major chemicals in tobacco smoke condensate that form DNA adducts in the
bladder of smokers. In Aim 1, we will conduct studies with cigarette smoke extract (CSE) and human bladder
cells incubated alone or in co-culture with hepatocytes to assess the role of liver metabolism in DNA damage of
the bladder. The panel of DNA adducts formed in bladder cells with CSE will serve as a guide to facilitate the
characterization of the DNA adductome of the urothelium of smokers and nonsmokers undergoing bladder
cancer surgery in Aim 2. Some procarcinogens in CSE can reach the bladder and undergo bioactivation by
P450s expressed in the bladder, particularly aromatic amines and HAAs. Therefore, in Aim 3, we will examine
the urinary exposome of AAs and HAAs in smokers participating in a tobacco cessation study by novel mass-
tagging methods to measure the totality of these potential bladder carcinogens in urine, and assess the capacity
of bladder enzymes to bioactivate these compounds.
Our research is relevant to NIH's mission on public health. Our studies will provide a greater understanding about
genotoxicants in tobacco smoke the environment that damage bladder DNA and contribute to bladder cancer.
By merging chemical exposures and DNA adducts with mutational data, clues about the identities of
environmental, dietary and endogenous genotoxicants can be established to identify subjects at risk for bladder cancer.
Once identified, pragmatic measures can be taken to reduce human exposure to chemicals, by changes in life-
style or mitigation of environmental exposures, which are probably the most efficient means of chemoprevention.

Public health relevance
Narrative The major chemicals in cigarette smoke that damage DNA of the bladder, a target organ of tobacco carcinogenesis, will be characterized in human bladder cells and in co-culture with hepatocytes, to assess organ-organ interactions. Thereafter, the tobacco exposome and DNA adductome of the urinary bladder of cancer patients will be characterized by mass spectrometry to identify major DNA damaging agents in tobacco smoke and the environment that can contribute to the etiology of bladder cancer.